University of Massachusetts Center for Clinical and Translational Science

Contact PD/PI: Luzuriaga, Katherine
PROJECT SUMMARY/ABSTRACT – O. OVERALL
The UMCCTS was organized in 2006 and NIH-funded in 2010 (renewed 2015), with the vision of improving
health and health care delivery by advancing the science of translation, by catalyzing high-quality research
across the translational spectrum, and by building and supporting a robust translational workforce. Our
overarching goal is to speed the development of new products and approaches to advance patient care and
community health. As Massachusetts’ only public university system (UMass) partnered with 2 of the state’s
safety net clinical systems (UMass Memorial Health Care, UMMHC; Baystate Health), we share an enduring
focus on public engagement and societal benefit. The UMCCTS engages a broad range of stakeholders
(communities, patient groups, foundations, industry, NCATS and CTSA hubs) to ensure that the research we
support and workforce we train address problems important to the communities we serve. With our partners,
we identify important problems and needs, develop and validate enabling platforms, provide resources that
facilitate transdisciplinary team science, and educate the next generation of investigators. We use data and
analytics to generate knowledge, apply that knowledge to improve performance, then use lessons learned to
inform and refine the next improvement cycle. UMCCTS Workforce Development programs ensure the future
sustainability of the clinical and translational research (CTR) enterprise.
Our 5 Specific Aims correspond to the 5 NCATS strategic goals stated in the NCATS FOA and build on our
prior successes: Aim 1: Workforce Development: Build and support a transdisciplinary CTR workforce with the
knowledge, skills, and institutional environment to advance high-impact translational research; Aim 2:
Collaboration/Engagement: Engage stakeholders throughout the translational process to optimize evidence-
based, community-integrated research practices and apply these practices to specific projects that improve
individual and population health; Aim 3: Integration Across the Lifespan & Underrepresented or Disadvantaged
Populations: Improve insights and practices that ensure that discoveries are translated to all who might benefit;
Aim 4: Methods & Processes: Develop, test, and share innovative solutions to critical gaps in the translational
research process from discovery to community; Aim 5: Informatics: Develop, demonstrate, and disseminate
informatics innovations that accelerate both translational science and translational research operations and
that provide the essential evidence base for learning health systems.
Abbreviations: CECC - Community Engagement and Collaboration Core; CRPG - Clinical Research
Professionals Group; D3Health - Center for Data-Driven Discovery in Health Care; PEPP - Preparing
Engineers for Professional Practice; SPRC - Science Participation Research Center; TRAcs - Translational
Research Accelerator; UMA - UMass Amherst; UMB - UMass Boston; UMD - UMass Dartmouth; UML -
UMass Lowell; UMMHC - UMass Memorial Healthcare; UMMS - UMass Medical School
Page 185
Project Summary/Abstract
Contact PD/PI: Luzuriaga, Katherine

Public health relevance
PROJECT NARRATIVE – O. OVERALL The University of Massachusetts Center for Clinical and Translational Science (UMCCTS) provides innovative education and career development programs, catalytic pilot grant programs, and cost-effective core services that accelerate the translation of discoveries into practical solutions that improve human health. Page 186 Project Narrative